Physiomarker for early, equitable cerebral palsy prediction

PROJECT SUMMARY/ABSTRACT
Significance: Cerebral palsy (CP) is primarily recognized as a motor disability but is often accompanied by
significant comorbidities that impact overall development, quality of life, and environmental engagement. Many
infants at high risk for cerebral palsy start their journey in the neonatal intensive care unit (NICU) due to being
born prematurely. CP is particularly prevalent in Black infants, underscoring critical health disparities that
demand attention. Early identification is vital, as targeted therapies post-NICU can enhance developmental
trajectories. However, current diagnostic methods for CP are not consistently accessible across all NICUs,
highlighting the need for a universal screening tool similar to the hearing screen to facilitate timely referrals for
advanced evaluation and CP-specific interventions. All NICU infants require continuous vital sign monitoring,
presenting an opportunity for early risk assessment through analytics that identify central nervous system
dysfunction. Our goal is to develop a novel physiologic biomarker ("physiomarker") for CP risk by analyzing
continuous NICU waveform and vital sign data. Preliminary data indicate that infants later diagnosed with CP
exhibit distinct heart rate patterns during their NICU stay. Our innovations include Highly Comparative Time
Series Analysis and the FAIRSCAPE platform for global data sharing, enabling detection of abnormal
cardiorespiratory patterns linked to CP and fostering collaboration among researchers. We will utilize both high-
resolution (250 Hz) waveform data and universally accessible low-resolution metrics to create a scalable and
equitable screening tool for all NICUs. Aim 1: Identify cardiorespiratory control signatures linked to CP using
high-resolution waveform data, analyzing heart rate variability, apnea patterns, and cardiorespiratory coupling to
detect central nervous system dysregulation. Aim 2: Develop a physiomarker for CP risk using low-resolution
heart rate and pulse oximeter data (0.5 Hz), universally available in all NICUs, guiding early and equitable
referrals for advanced testing and targeted therapies. Our experienced investigator team has NIH-funded
research and access to extensive preterm infant data from eight NICUs across the U.S. Strong clinician-data
science partnerships highlight the importance of interdisciplinary collaboration in developing predictive models.
We have successfully predicted multiple adverse outcomes, including neurodevelopmental impairment, through
our datasets and validated methodologies. Successful completion of this proposal will result in a translational
physiomarker for CP risk, providing accessible early CP risk screening akin to the hearing screen and facilitating
timely interventions that can alter the lifelong trajectory of high-risk infants and families.

Public health relevance
PROJECT NARRATIVE Atypical heart rate and oxygen saturation patterns can offer critical insights into brain injury or dysfunction in preterm infants. We are developing cardiorespiratory physiomarkers to identify those at the highest risk for cerebral palsy in the Neonatal Intensive Care Unit. This is a public health priority because early detection of these conditions enables earlier interventions, which can significantly improve motor, social, and communication outcomes, ultimately reducing the long-term burden of neurodisability.